ACTG 364--COMPARISON OF VIROLOGIC EFFICACY OF NELFINAVIR AND OR DMP 266

Compare the safety and virologic efficacy of nelfinavir and DMP-266 when used separately or in combination with nucleoside-containing regimens for patients previously in ACTG 302 or 303.